Data Management Analysis and Resources Dissemination Core

PROJECT SUMMARY
The Baylor College of Medicine Genomic Center for Infectious Diseases (GCID) proposal seeks to provide a
comprehensive, large scale genomics program for NIAID with the goal of enhancing our understanding of host
and microbiome interactions related to infectious disease genomics. Large heterogeneous datasets will be
evaluated and characterized using new and proven analytical methods to further our understanding of how
polymorphisms (host or microbe) contribute to mechanisms of pathogenesis. The resultant data will be used in
the development of new tools to diagnose, prevent and treat infectious diseases. As an integral component of
the BCM Genomics Centers for Infectious Disease, the Data Management, Analysis and Resource
Dissemination (DMARD) Core will be responsible for supporting the program by managing sample tracking via
LIMS, data management, data analysis and data dissemination for the four BCM GCID research projects:
bacterial, viral, fungal, and parasite. The DMARD will also focus on bioinformatic tool developments that seek
to optimize existing protocols, as well as create new workflows in response to new sequencing technologies
and molecular techniques. For this effort we will bring together analytical expertise in human genetics and
large scale genomics from the Human Genome Sequencing Center (HGSC) with microbial, viral, and
metagenomics experience from the Center for Metagenomics and Microbiome Research (CMMR). Integrated
analysis will be managed by senior faculty in the BCM Multi-Omics Data Analysis Bioinformatics Core working
in close collaboration with project PIs. All resulting data and tools will be made available to the wider GCID
and NIAID community via a custom web based analysis portal built in collaboration with DNAnexus, a
commercial cloud-based genomics platform.!